Heath Outcomes Post-Eviction Moratoria (HOPE-M)

PROJECT SUMMARY/ABSTRACT
Experiencing the threat of eviction is associated with mental distress, and Black, Hispanic, and female renters
are most affected by evictions. Eviction moratoria were short-term housing interventions designed to limit the
spread of COVID-19 and maintain housing stability. Travis County (Austin, TX) residents experienced a strong
local moratorium (i.e. blocked all stages of eviction process) through December 2021. In contrast, Harris County
(Houston, TX) residents never experienced a local moratorium, and were dependent on the state moratorium,
which ended in May 2020. Since moratoria have ended, evictions and the cost of basic needs have dramatically
increased. In a post-moratoria period, the question remains whether prior exposure to a strong local moratorium
policy reduces post-moratorium mental distress in the presence of ongoing economic disruptions. The Heath
Outcomes Post-Eviction Moratoria (HOPE-M) Study, proposes to use a mixed methods sequential explanatory
design to examine how prior exposure to a strong local moratorium influences the direct and indirect paths linking
the threat of eviction with post-moratorium mental health over time. To create the sample 2 sources of data will
be used. The first source of data will be used to identify individuals who had eviction filing post state/local
moratorium (Harris: June 2020–December 2023; Travis: January 2022–December 2023). This data was
collected through the Eviction Tracking System. The second source of data will facilitate identification of
individuals at risk for eviction but not filed using data generated by Dr. Thomas' (co-I) Housing Precarity Risk
Model (HPRM). Renters living in neighborhoods with high eviction risk after the state/local moratorium ended
will be selected on matching criteria based on respondent's household characteristics that align with the top
predictive variables in the HPRM (e.g., race) as well as dominate characteristics found in prior eviction research
(e.g., sex). Participants [Harris County (n= 1,000) Travis County (n=1,000)] will be surveyed at baseline, 6
months, 12 months. Analyses will include longitudinal mixed effect models and focus groups and photo elicitation
interviews will be used to triangulate the findings. Aim 1. Assess the moderating impact of prior local eviction
policy exposure on the link between experiencing the threat of eviction and post-moratorium mental health over
time and how this varies by race/ethnicity and sex. Aim 2. Examine the mental health disparities in aim 1 as a
function of the mediating effects of economic hardship and psychosocial stressors. Aim 3. Explore the decision-
making processes and self-assessment associated with making economic decisions to avoid eviction and how
this contributes to psychosocial distress. With every state having shortage of affordable and available rental
homes, this study is significant to policymakers and legal aid organizations who have the ability to inform housing
policies. The use of ETS's court-ordered eviction records (over self-reports) and the use of the HPRM to include
adults with similar characteristics and at-risk for eviction is an innovative approach to improving sample selection.
This approach complements NIMH's Strategic Plan, Goals 2 and 3 and is supported by numerous stakeholders.

Public health relevance
PROJECT NARRATIVE In 2020 state-level moratoria that blocked earlier stages of the eviction process were associated with a reduction in mental distress, but since the moratorium ended, eviction and the cost of basic needs has increased, causing additional economic and psychosocial burden among renters at risk for eviction. Research is needed to determine if prior exposure to a strong local eviction moratorium reduces post-moratorium mental distress in the presence of ongoing economic disruptions. With every state having an inadequate supply of affordable rental housing for the lowest income renters, this study is highly relevant to policymakers and legal aid organizations who have the ability to inform housing and mental health policy.